RNA Sequencing and Data Analysis Core

RNA Sequencing and Data Analysis Core Summary:
The goal of the RNA Sequencing and Data Analysis Core is to provide a centralized service for RNA
sequencing and bioinformatics needs of the program. The benefits of this core include resources and expertise
to perform RNA sequencing experiments, access to the most up-to-date equipment, kits and concepts, and
cutting edge methods and tools for sequencing and integrative omics analyses.
This team is particularly skilled in small RNA and mRNA (long) RNA sequencing and analyses, with
emphasis on integration of these data with other -omics datasets. Many of the services provided by the Core
have been developed and optimized at Vanderbilt University Medical Center (VUMC) by members of the
leadership team, including cutting-edge protocols and analysis pipelines for small RNA sequencing of
extracellular RNAs. The Core personnel have complementary expertise in biotechnology, bioinformatics, and
biostatistics. The Core will 1) perform high throughput small RNA and total RNA sequencing, as well as other
sequencing experiments; 2) provide multi-omics data analysis and interpretation; 3) develop novel integrative
methods to discover key regulators in extracellular RNA biogenesis and function in colorectal cancer.

Public health relevance
Narrative: The RNA Sequencing and Data Analysis Core will provide expertise and support for all projects in sequencing experiments, multi-omics (eg RNA-Seq and proteomics) data analysis, interpretation, data sharing and integration. We will perform small RNA and total RNA sequencing, provide state-of-the-art multi-level omics data, and develop novel integrative omics methods to provide a comprehensive understanding of exRNA biogenesis and function in colorectal cancer.